Training In Cell and Gene Therapy

PROJECT SUMMARY
This application from the Center for Cell and Gene Therapy (CAGT) / Baylor College of Medicine (BCM)
describes a comprehensive training program in cellular and genetic therapies for both graduate students and
postdoctoral fellows. This rapidly expanding area of translational research remains deficient in comprehensive
training schemes for individuals who wish to address basic and clinical translational aspects using these
biological agents. A stimulating program of education and laboratory training from high quality and diverse
mentors should continue to attract promising candidates, including under-represented minorities, to this
emerging field and increase the likelihood that they will pursue careers as translational researchers. Translation
of basic research discoveries to clinical practice has become increasingly complex, and advances in basic
research can now only be efficiently implemented when teams of investigators collaborate to validate these novel
strategies in the clinic. This type of translational research training requires a dedicated team of mentors with
diverse but complementary skills. The proposed training exploits the outstanding biomedical curricula and
experienced faculty within BCM and CAGT. A cadre of 27 faculty members with research interests that include
vector design and targeting, stem cell biology, molecular and cellular genetics, immunotherapy, gene therapy
and stem cell transplantation will be available to mentor graduate students and both MD and PhD postdoctoral
fellows. Major strengths of the program are; (1) targeting of rigorous basic biomedical science and clinical
research training toward a translational goal; (2) established and multilevel integration with the proven scientific
excellence of cell biology and genetics research training programs at BCM; (3) involvement of mentors, including
program director and co-directors, who are diverse in gender and race and have a wealth of successful
experience in translational research and in training equally diverse young investigators (4) availability of
exceptional resources such as the GMP laboratories and experienced regulatory staff for training. Frequent
opportunities to present recent research findings at annual retreats sponsored by CAGT and academic
departments within BCM. augment the formal course work and laboratory training. During the 18.5 years of
funding, our approach has successfully trained 49 graduate students and 35 postdoctoral fellows in translational
cell and gene therapy research. 95% of trainees who have completed training remain in careers in science within
the field with 5% in private practice but engaged in clinical research. In the full 18.5 years that this T32 has been
funded, 51% of trainees have been male, 49% female and 20 of the 84 trainees (24%) have been from
underrepresented groups (13 Hispanic, 6 African American and 1 American Indian). All positions on this T32
have been filled at all times and we request an increase in support to enable us to meet the needs of trainees to
provide a strong foundation for translational research careers in this burgeoning area.

Public health relevance
PROJECT NARRATIVE This proposal will recruit and train diverse young researchers so that they can translate cell and gene based therapies from basic science laboratories into clinical development. These therapies hold great promise for regenerative medicine, cancer and other disorders, but can only be implemented after the specialized training provided by this award.